CTSA K12 Program at The Ohio State University

The overarching goal of the Ohio State University (OSU) Center for Clinical and Translational
Science affiliated K12 program is to develop a multi-disciplinary cadre of well-trained, early-stage
faculty investigators through individualized training to engage fully, succeed, and lead in clinical
translational research and science (CTR/CTS). The program is open to eligible early career
faculty members at the Ohio State University (OSU) and Nationwide Children’s Hospital (NCH).
To accomplish this, we propose the following Specific Objectives (S.O.):
S.O.1. Provide training to foster the development and long-term success of early career faculty
engaged in clinical and translational research.
S.O.2. Provide mentorship training and monitor progress for scholars, mentors, and mentor mentee dyads.
S.O.3. Support the development of skills for scholars to lead in translational science.
S.O.4. Conduct ongoing evaluation of program and scholar outcomes for continuous
improvement.
Highlights of programmatic training elements include: development of monitored individual
training plans (IDP); structured communication and grant writing preparation; leadership skill
development; understanding and thriving in a team science environment; training in responsible
conduct of research; training in research ethics; training in working with research teams and
participants; research design and data interpretation; and training in rigor and reproducibility in
the conduct of research. Program elements will be opened to other institutional and individual K
scholars at OSU and NCH. Four early career K12 scholars will be trained with two-year
appointments (2 per year) supported by the K12, followed by institutional support to continue a
third year of K12 training. Scholar success will be defined based on research productivity
(particularly independent research funding in CTR/CTS) and progression in the characteristics of
a translational scientist. Scholars will be monitored during the K12 based on their IDPs, and after
the K12 to evaluate career progression and participation and leadership in clinical and
translational research and clinical and translational science. A RE-AIM and Logic Model
framework will be used for programmatic evaluation and programmatic adaptation. The OSU
campus research environment and participating communities, and the ability to look at questions
across the lifespan through our partnership with NCH provides a range of opportunities to train
future leaders in clinical and translational research and science.

Public health relevance
Project Narrative: This institutional training grant will train early career faculty at the Ohio State University and Nationwide Children’s Hospital. The goal is to develop individualized plans and comprehensively train faculty to participate in and then lead in clinical and translational research, to ultimately improve human health for all.